Exposure Characterization and Modeling Core

A. ABSTRACT
The Exposure Characterization and Modeling Core (ECMC) is critical to the ability of the Center for Community Health: Addressing Regional Maryland Environmental Determinants of Disease (CHARMED) to achieve its central goals of fostering innovative interdisciplinary research in environmental health and translating knowledge into action to address community environmental challenges in the Maryland region. The Specific Aims of the ECMC are to (1) Provide resources and support for planned and ongoing research projects by Center investigators, including pilot projects and projects related to Center initiatives; (2) Provide expert consultation and guidance for CHARMED investigators and community members related to measurement needs, statistical data analysis, and results interpretation; (3) Develop new technologies, modeling frameworks, and statistical methodologies for Center needs. The ECMC will be the central source for exposure assessment support for ongoing NIEHS and Center Pilot projects. ECMC experts will also serve as scientific mentors for the Mentored Career Awardees and Pilot Project awardees. The ECMC will lower the financial and technical barriers for conduct of CHARMED research, and this important support would not be available were it not for the Center grant mechanism.